IL-15 Therapy Combined with TGF-Beta Blockade for Sustained HIV Remission

The overall goal of this proposal is to evaluate the safety and therapeutic potential of a novel strategy towards a cure of HIV
infection. The proposed treatment combines soluble IL-15/IL-15Rα with a TGF-β pathway blockade and therapeutic
vaccination to enhance/restore function of anti-viral immunity that will lead to sustained viral remission following anti-
retroviral therapy (ART) interruption against HIV, using the SIV/Rhesus macaque (RM) model. Persistence of viral
reservoirs and dysfunctional anti-HIV immunity represent two major obstacles that must be addressed to achieve sustained
viral remission via blocking viral reactivation in the absence of ART. ART is highly effective in controlling virus replication
but does not significantly improve T cell function and fails to eliminate viral reservoirs. Anti-viral CD8 T cells are critical
for the control of HIV/SIV replication, yet these cells are largely excluded from secondary lymphoid organs which host a
significant population of viral reservoirs during ART, primarily in T follicular helper cells (Tfh) that reside in B cell follicles
and germinal centers (GC). Thus, novel therapies that that not only restore/enhance function of both anti-viral CD8 T cells
and NK cells, but also promote follicular homing of these cells while viral reservoirs are being reactivated will significantly
enhance clearance of infected cells within lymphoid tissues, thereby contributing to sustained viral remission following
analytical ART interruption (ATI). Our preliminary data demonstrate that treatment with the TGF-β pathway inhibitor
galunisertib (GAL) improves anti-retroviral bioavailability in human lymphoid endothelial cells and cytokine (IL-
15/IL15Ra) treatment in vivo markedly enhances the magnitude, proliferation and cytotoxic potential of SIV-specific CD8+
T and NK cells with follicular homing potential, which is critical for the reduction of reemerging viremia post ART
interruption. In addition, in vitro stimulation of chronically infected PBMC with IL-15/IL15R therapy plus GAL treatment
resulted in higher proliferation anti-viral CD8 T cells and NK cells. Importantly, in vivo administration IL-15/IL15Ra plus
GAL treatment in ART treated macaques enhanced antiviral CD8 T cell and NK cell function. Given these highly
encouraging results, we propose to comprehensively test the effects of IL-15/IL-15Ra therapy plus GAL treatment either
alone or in combination on different T and NK cell subsets during chronic SIV infection under the umbrella of ART (Aim
1), and investigate how these changes affect viral reservoirs under ART and viral control after ART interruption (Aim 2).
Last, we will combine the optimal cytokine therapy with vaccination to further enhance the magnitude and breadth of SIV-
specific CD8 T cell responses that we hope will further improve the therapeutic benefit (Aim 3). These studies will advance
our knowledge about how IL-15/IL-15a therapy plus GAL differentially influence the reservoirs and function of different
subsets of T and NK cells during chronic SIV infection and ART, and what immune mechanisms are induced by dual
therapy and vaccination, and how these contribute to control of chronic SIV/HIV infection in vivo.

Public health relevance
HIV remains a leading cause of morbidity and mortality worldwide, and while antiretroviral therapy has markedly improved the clinical outlook for patients, the therapy needs to be maintained for life to block renewed viral replication. In efforts to achieve permanent control of HIV replication without continued ART (HIV cure), this project proposes to explore the safety and therapeutic potential of a novel treatment strategy, by testing the synergy between an immune enhancing cytokine, IL- 15 and IL-15 receptor alpha, while blocking the immune dampening pathway of another cytokine, transforming growth factor beta. This approach will enhance antiviral responses while also reactivate cells housing latent virus towards their elimination, in addition this strategy will then be further combined with a novel therapeutic vaccination against HIV/SIV to attempt to achieve durable control of viral replication beyond antiretroviral treatment